Regulation of binge-like ethanol intake by arcuate POMC projection neurons

ABSTRACT
The endogenous opioid system is strongly implicated in the rewarding, reinforcing, and motivational effects of
ethanol, as evidenced by the established clinical efficacy of the opioid receptor antagonists naltrexone and
nalmefene in reducing ethanol intake, relapse propensity, and craving. Animal studies have demonstrated that
ethanol activates various opioid peptide-containing circuits within the brain, including regions of the
mesocorticolimbic reward circuitry and amygdala. Recently we have generated multiple lines of evidence
indicating that ethanol activates a subset of neurons within the arcuate nucleus (ArcN) of the hypothalamus
expressing pro-opiomelanocortin (POMC), which gives rise to numerous bioactive neuropeptides including -
endorphin. Using patch clamp electrophysiology, we observed that bath application of ethanol (5-40 mM)
increases the firing frequency of ~35% of recorded ArcN POMC neurons. Similarly, using FosB
immunohistochemistry, we demonstrated that binge-like ethanol intake activates approximately a subset of ArcN
POMC neurons, the majority of which synthesize -endorphin vs. -MSH. Retrograde tracing revealed binge-
like ethanol intake primarily activates ArcN POMC neurons projecting to the amygdala, with fewer activated
neurons projecting to the ventral tegmental area (VTA) or nucleus accumbens (NAc). Surprisingly, chemogenetic
modulation of ArcN POMC neurons without subpopulation delineation had no effect on ethanol intake. However,
we speculate that these lack of effects were due to the non-specific nature of activation of a number of ArcN
POMC neuron containing subcircuits. Baseline sex differences in binge-like ethanol intake were observed, where
female mice consumed significantly more ethanol than their male counterparts, and we observed that ER is the
primary female sex hormone receptor located on ArcN POMC neurons as compared to ER or progesterone
receptors. Together, these observations have led to our overarching hypothesis that ArcN POMC neuron
projections to regions of the mesolimbic reward system regulate binge-like ethanol intake in a sex-dependent
manner primarily via ER dependent mechanisms. To test this hypothesis, we have formulated the following
inter-related yet independent Specific Aims. In Aim 1, we will determine the effects of ethanol on the
neurophysiological properties of ArcN POMC projection neurons. In Aim 2, we will determine the effects of
chemogenetic modulation of specific ArcN POMC efferent projection neurons on binge-like ethanol intake.
Finally, in Aim 3, we will determine the role of ER on POMC neurons in the regulation of binge-like ethanol
intake and potential interactions with midbrain dopamine neurons. Together, these studies will elucidate specific
opioid circuits and mechanisms regulating binge-like ethanol intake, which will guide the improvement of
neuromodulatory and/or pharmacological approaches for the treatment of alcohol use disorders.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE The goal of the studies outlined in this proposal is to explore the neural circuits utilizing pro-opiomelanocortin (POMC) derived peptides in regulating binge-like ethanol intake as well as sex differences in ethanol consumption. These studies will provide novel information on the mechanisms by which binge-like ethanol intake engages and is regulated by components of the endogenous opioid system. Information gained from this line of research will ultimately guide the development of neuromodulatory or other types of approaches for reducing binge-like ethanol intake, which may reduce the medical, socioeconomic and legal costs of alcohol abuse to society.